Elucidating the effects of sublingual tablets containing buprenorphine on dental caries, and development of a novel formulation.

PROJECT SUMMARY/ABSTRACT
Opioid use disorder (OUD) is a severely debilitating condition affecting nearly 10 million Americans. The
sublingual drug product, Suboxone, which contains buprenorphine and naloxone, is the most frequently
prescribed medication to treat OUD. In 2022, the FDA released a warning after several reports of patients
prescribed sublingual forms of buprenorphine that exhibited severe dental caries and tooth loss. Furthermore,
these issues arose in patients without prior dental concerns. Case reports and epidemiological evidence have
supported these findings; yet the reason for this association is not understood. Dental caries (ie. tooth decay) is
a chronic, polymicrobial, biofilm-based disease resulting from microbial dysbiosis and environmental changes in
which microbial fermentation byproducts like lactic acid accumulate, demineralize the tooth structure, and can
lead to severe odontogenic infections. Certain conditions favor the growth and persistence of aciduric and
acidogenic microorganisms, including the cariogenic Streptococcus mutans and the yeast pathobiont Candida
albicans at the expense of health-associated microorganisms, hence forming a cariogenic, dysbiotic microbiome.
Sublingual tablets containing buprenorphine also contain several pharmaceutical excipients including binders,
taste enhancers, and solubilizers, including lactose, mannitol, and citric acid. Our preliminary data suggests that
these excipients combined promote the growth and biofilm formation of cariogenic microorganisms S. mutans
and C. albicans. Importantly, they can do so at the estimated concentrations in the oral cavity following
administration of the drug product. Thus, we hypothesize that the extended use of the current marketed drug
products containing fermentable sugars and acidic excipients result in a shift in the oral microbiome by favoring
cariogenic species and thus promoting the development of dental caries. In this proposal, we seek to address
this concern by determining whether the current sublingual tablets containing buprenorphine promote a
cariogenic microbiome and developing a new oral health promoting formulation that prevents the devasting
dental effects associated with the currently marketed formulations. In Aim 1, the PI will first determine the growth
and acidogenicity of S. mutans and C. albicans cultures exposed to each excipient and whole tablet. Then
biofilms formed by these two microorganisms in response to the tablet will be examined by performing biofilm
biomass assays and confocal microscopy. Metagenomic analysis will then be performed using an ex vivo dental
plaque microcosm model after exposure to the tablets. In Aim 2, the PI will formulate a novel tablet formulation
that replaces identified cariogenic excipients with validated non-cariogenic and dental safe excipients.
Successful completion of the proposed studies will result in an improved formulation aiding in the prevention of
dental caries, thus significantly improving the health and quality of life of OUD patients, and patient's willingness
to accept buprenorphine therapy. Furthermore, the proposed training plan will cultivate the PI's development into
a clinician-scientist through coursework, inter-disciplinary mentorship, dental practice, and rigorous research.

Public health relevance
PROJECT NARRATIVE Sublingual buprenorphine is a safe and effective medication to treat Opioid Use Disorder (OUD); a condition that plaques our society with over 10 million Americans affected. However, sublingual drug products containing this potentially life-saving drug has been associated with severe dental caries and tooth loss. Findings from this proposal will decipher which components of the formulation are responsible for this observed increase in caries incidence and will provide a novel formulation to prevent any formulation dependent increase in caries risk or progression, likely also boosting patient acceptance and compliance of buprenorphine therapy indeed.